Chromosome Archae-tecture: Conserved principles of chromosome organization

PROJECT SUMMARY
The three-dimensional organization of DNA within cells is of profound importance for the appropriate and timely
execution of gene expression programs. Recent advances in experimental approaches have allowed the
elucidation of the conformation of chromosomes of bacteria and eukaryotes with unprecedented resolution.
Bacterial chromosomes are organized into locally folded units and chromosome arms either side of the origin of
replication are juxtaposed processively by the action of SMC proteins. In contrast, metazoa have large-scale
domains along the linear order of the chromosome, these fall into two distinct types that exclusively associate to
form two distinct classes of higher-order compartment. To date, essentially nothing is known about the
conformation of chromosomes from organisms in the third domain of life, the Archaea. Many aspects of the
information processing (DNA replication, gene transcription) machineries of archaea and eukaryotes are
fundamentally related and distinct from those of bacteria. This is despite the prokaryotic nature of archaea, their
morphological similarities to bacteria and the presence of simple circular chromosomes, as in many bacteria.
Strikingly, preliminary data reveal that the chromosomes of hyperthermophilic archaea of the genus Sulfolobus,
like eukaryotes, and distinct from bacteria, possess a large-scale domain architecture with higher-order
organization into two distinct classes of compartment. This provocative observation suggests that the
fundamental logic of chromosome organization may predate the bifurcation of archaeal and eukaryotic lineages.
The preliminary data will be extended to provide a high-resolution 4-D roadmap of the dynamic structure of the
archaeal genome. A novel SMC-related protein is implicated in coordinating the structure of the genome and its
role will be investigated both in vivo and in vitro using a combination of genetic and biochemical approaches.
Finally, the causality of the interplay between the cellular gene expression program and chromosome
architecture will be determined.
Taken as a whole, this work will exploit a unique and simple model system to elucidate the mechanisms and
evolution of the conserved principles governing the higher-order organization of genomes.

Public health relevance
PROJECT NARRATIVE The interplay of the three-dimensional shape of chromosomes and DNA-based processes including gene expression and DNA replication is complex and can be causal and consequential in nature. Our preliminary data reveal that the genomes of prokaryotic archaeal organisms have 3D organization with a striking resemblance to that of higher eukaryotes and, exploiting this uniquely simple system, we will investigate the establishment and temporal regulation of the genome’s structure. In addition, we will determine the factors that govern this process and how DNA-based transactions influence the overall higher-order organization of the chromosome.